Diversity Supplement for Spatial Organization of the Mitochondrial Inner Membrane

Project Summary Mitochondria are double-membrane bound organelles that perform many crucial cellular functions, including nucleotide and amino acid metabolism, cellular phospholipid and ion homeostasis, and their most notorious function, generation of cellular energy via oxidative phosphorylation. Mitochondrial form and function are tightly linked. The ability of the organelle to efficiently perform respiration depends on the correct spatial organization of the mitochondrial inner membrane into elaborately shaped morphological domains, including cristae, the hallmark of the organelle. Cristae morphology defects lead to reduced cellular respiration and is a phenotypic consequence of a number of diseases, including neurodegenerative disorders such as Alzheimer’s and Parkinson’s Disease. Despite their importance, we have minimal mechanistic understanding of how cristae are formed and organized within the organelle. Recently, the Mitochondrial Contact Site and Cristae Organizing System (MICOS) complex was identified as a master regulator of spatial organization of mitochondria. I previously determined that MICOS is organized into two non-redundant subcomplexes that independently assemble and localize to cristae junctions, a key structural element of the mitochondrial inner membrane. Despite our progress, we have minimal mechanistic understanding of how MICOS contributes to the number, position, and morphogenesis of cristae membranes. We will address these deficits by exploring the molecular basis of MICOS function in yeast cells and, using candidate and forward genetic strategies, determine how MICOS is regulated to fine tune cristae architecture in human cells. This work will lead to insight into the spatial organization of mitochondria and the form-function relationship of the organelle, provide the basis for the future development of my research program, and give us molecular insight into the disorganization of mitochondrial membranes that occurs as a consequence of a number of human diseases.

Public health relevance
Project Narrative Mitochondria are double-membrane bound organelles that perform many cellular functions, including the generation of energy via respiration. Spatial organization of the mitochondrial inner membrane is crucial for efficient energy production, though the mechanisms that generate mitochondrial architecture are poorly understood. The proposed work will determine the mechanistic and functional roles of the evolutionarily- conserved MICOS complex, a key modulator of mitochondrial morphology, and identify novel regulators of its function with the long-term goal of identifying therapeutic approaches to alleviate diseases with underlying mitochondrial dysfunction.